ARISEN (Autoimmunity, Rasmussen’s, Inflammation & Status Epilepticus research Network)

Pilot Projects Core: Project Summary
The aim of the Pilot Projects core is to create a program in which investigators could apply for pilot funding for
projects leveraging ARISEN (Autoimmunity, Rasmussens, Inflammation & Status Epilepticus research Network).
The goal of this pilot funding would be to support studies aimed at advancing clinical trial readiness, management
and/or treatment of autoimmune encephalitis, Rasmussen syndrome and new onset refractory status epilepticus
(NORSE). We will encourage investigators to expand beyond the resources of the ARISEN consortium to push
the field further and foster further collaborations. These collaborations can then be rolled back into the ARISEN
consortium for longitudinal growth of the network. This pilot/feasibility projects core is essential to continuing rare
disease research as it provides funding opportunities to encourage investigators with diverse expertise and
interests to leverage ARISEN’s resources, clinical data, biospecimens, and registry. We will also partner with our
patient advocacy groups for the call for applications and review of applications. We will initially support one pilot
project per year and aim to increase that to two per year with financial partnership with and support from our
patient advocacy groups. The investigators involved in the Pilot Projects core are an experienced, diverse group
of individuals from different institutions and different backgrounds. We would select those project applications
that are aimed at improving the diagnosis, management, and/or treatment of the diseases in this registry. Aim 1
will solicit pilot project applications to advance research in autoimmune encephalitis, Rasmussen syndrome, and
NORSE and Aim 2 will help to establish a rigorous, unbiased, and transparent review process for grants, and
select projects that achieve the goals of ARISEN. For the review process, we will use a similar process as used
by NIH study sections. We will include a diverse reviewer pool and include junior investigators from the Career
Enhancement Program to provide training on the grants review process. This will allow for a review and selection
process that is rigorous and unbiased, while also providing training for junior investigators. All reviewers will take
NIH online reviewer training and implicit bias training offered by Emory University. The review criteria would
include: 1) Relevance to the autoimmune encephalitis, Rasmussen syndrome, and NORSE; 2) Significance and
the potential for this project to advance the field; 3) Rigor of the experimental plan; 4) Identification of clear
outcome metrics, 4) Investigator qualifications and expertise to carry out the pilot project, with priority for Early
Stage Investigators; 5) Potential for future funding; 6) Promoting collaboration across the ARISEN participating
sites, including leveraging existing resources and infrastructure; 7) Feasibility: the likelihood that the project can
be achieved in a one-year timeline and with the budget proposed. Aim 3 will oversee pilot/feasibility projects and
the outcomes of the projects including additional grants and publications. The goal of this core is to fund projects
that will generate data for potentially highly impactful studies, have demonstrated empirical proof-of-concept,
and will gain access to external funding sources.